FASEB SRC: The 2nd Acute Kidney Injury Conference: From Bench to Bedside

Project Summary
Acute kidney injury (AKI) is an increasingly prevalent worldwide problem that has a significant impact on patient
mortality and morbidity, including a marked increased risk of progressive chronic kidney disease (CKD). Despite
this, no therapies have been shown to accelerate recovery or prevent progression to CKD in patients with AKI.
There are several reasons for this, but a major factor has been the lack of effective collaborative pipelines
between bench researchers studying the mechanisms and therapeutic approaches for AKI, and clinical scientists
implementing hypothesis testing clinical trials in patients with AKI. However, aside from the annual scientific
meeting of the American Society of Nephrology (ASN), there are no other established forums that promote direct
exchange of ideas between the clinical and basic science AKI research communities. To address this, we are
seeking support for the 2nd FASEB “AKI from bench to bedside” conference, which will be held May 14th-
17th 2022, at the Banff Center for the Arts and Creativity in Canada. The aims of this conference series are:
1) to review state of the art and work in progress, basic, translational, and clinical research on AKI; 2) to provide
a platform to help develop new investigators trained to think in a more translational way about AKI; 3) to provide
a forum for networking across disciplines, including patient advocacy and URM scientists; and 4) to provide a
workforce development program for trainees with opportunities to meet and develop long-term mentoring
relationships with leaders in their field; career advice; and discussions about challenging topics for research
leadership including imposter syndrome and unconscious bias in research. This planned biannual meeting was
first held in 2019 in Asilomar, but the 2nd conference was delayed in 2021 in preference for an in-person meeting
in 2022, with greater opportunities for networking across disciplines. 30 experts and trainees (34% trainees; 50%
female or transgender; and 23% URM) who have confirmed attendance will provide state of the art and work in
progress talks on topical aspects of research in the basic and clinical science of AKI. These presentations will
be intermingled with additional abstract selected presentations largely from trainees, as well as an informal
poster session to encourage scientific interactions between diverse AKI scientists. With an enhanced drive for
sponsorship support, we will also defray the costs of registration to attract more trainees and junior faculty to the
meeting. On this basis, we expect the meeting will attract clinical and basic scientists from academia, and
investigators and leaders from companies involved in pre-clinical and clinical AKI research from across the globe.

Public health relevance
Project Narrative We are planning a FASEB Scientific Research Conference (SRC) focusing on Acute Kidney Injury (AKI), providing a focused conference on topical aspects of research and approaches in both the basic and clinical science of AKI. Experts from academic medicine and industry have been invited to provide state of the art talks on key, topical aspects of research in both the basic and clinical science of AKI, as well as recent advances in drug and therapeutic development for AKI. We anticipate that this meeting will attract investigators and trainees from academia and industry involved in different aspects of AKI research, and as such will provide a unique opportunity to foster new collaborative interactions between stakeholders.